Developing virtual reality programs to address social skills deficits in youth with ADHD

Project Summary
Children with ADHD often have social skills deficits that are not adequately addressed through clinical care or
school programs. Therapy or social skills training to address these deficits are often inadequate, irregular, or
inaccessible, with potential long-term consequences for children, their families, and society. Addressing deficits
in social-emotional functioning via group sessions, cognitive-behavioral therapy, or role-playing can improve
empathy and prosocial behaviors, but require time, engagement, and resources that families often struggle to
find. One manner to address these limitations is through virtual reality (VR), which can provide naturalistic yet
controlled environments in which users can experience interactions from multiple viewpoints and across a
variety of settings. OpenMindXR, LLC, is developing a suite of immersive VR programs that provide engaging,
replayable modules directed at improving social skills in children with ADHD, in a manner that is easy to
access at home. This content is presented within environments with modifiable audiovisual background
content, so users can begin with low-distraction virtual interactions and progress towards more realistic, high-
distraction levels. Based on our ongoing research, the OpenMindXR program will consist of three distinct
modules. In the PerspectiVR module, users experience virtual interactions, and then re-experience the
interaction from the virtual counterpart's point of view, to better understand the thoughts and feelings of
others. In the Social Skills Challenge module, users view scenes and are assessed for potential social-emotional
biases, and they can then identify and practice strategies for regulating emotions and behaviors. In the Virtual
Practice of Emotion Recognition (ViPER) module, users are assessed on their ability to identify specific
emotions in virtual counterparts and can work to adaptively improve their abilities. In our laboratory research,
children find these VR programs to be enjoyable, engaging, and easy-to-use. This proposal will convert and
update research software into a combined VR program available for home use on a VR headset. Following
development, we will undergo an iterative testing and feedback with 48 total families of children aged 9-15 with
ADHD, performed in four separate cohorts. During this testing phase, children with ADHD will use the
OpenMindXR program for a one-month period, with families providing feedback during and after this trial on
usability, enjoyment, and real-world behaviors. Following each cohort of 12 families, OpenMindXR will update
the program based on feedback and begin testing on the next cohort. In this manner, we plan to achieve the
following aims: (1) To complete development of a beta version of the Virtual Interaction Practice (VIP) Suite of
VR programs; (2) To assess usability of the VIP Suite by children with ADHD; and (3) To evaluate the impact of
the VIP Suite on social cognition and social skills. Satisfying these aims will promote continued development of
an accessible, adaptive, enjoyable VR program for children with ADHD, to empower them to improve their
social skills on their own, or to supplement clinical or school programs with additional support.

Public health relevance
Project Narrative Children and adolescents with attention-deficit/hyperactivity disorder (ADHD) often have social skills deficits that are not adequately addressed through clinical care or school programs. This project will allow OpenMindXR to further develop and test a suite of virtual reality programs aimed at helping youth with ADHD, with distinct modules aimed at assessing and improving social cognition and behavior within realistic virtual environments that vary in levels of audiovisual distraction. Children will complete a one-month trial of the program, and iterative updates will be made to optimize usability, enjoyment, and impact on real-world outcomes, based on feedback from families.